Development of a Tailored Intervention to Increase Veteran Enrollment in Cardiac Rehabilitation

Background: This Veterans Affairs (VA) Health Services Research & Development Career Development
Award resubmission is a five-year plan that will enable the candidate, a staff cardiologist and specialist in
cardiac rehabilitation (CR) at the VA Tennessee Valley Healthcare System, to develop and implement
interventions to increase CR enrollment in Veterans. CR is an outpatient program including prescriptive
exercise and cardiac risk factor education that is an essential therapy for patients with cardiovascular disease.
This proposal will develop a tailored intervention to increase Veteran enrollment in CR.
Significance/Impact: CR is widely underutilized, with less than 20% of eligible patients enrolling in CR
programs nationally. CR utilization is particularly low among Veterans, with only 10% of eligible Veterans
enrolling in CR programs. Though CR referral rates have risen substantially over the past decade, CR
enrollment has remained static. It is imperative to study barriers to CR enrollment among Veterans that have
already been referred to CR and develop interventions tailored to these individual barriers.
Innovation: The applicant will develop a tailored intervention for increasing CR enrollment using the Obesity-
Related Behavioral Intervention Trials model, a conceptual model for intervention development, as well as the
information-motivation-behavioral skills model, a theory of behavior change that allows individual tailoring.
Linking these models will produce new knowledge regarding behavioral intervention methodology as well as an
innovative clinical intervention that can be delivered by nurses and other clinical staff at VA facilities. The
proposed intervention aligns with current VA initiatives by supporting CR enrollment wherever is most
convenient for Veterans (including VA CR programs, non-VA CR programs, and home-based CR programs).
Specific Aims: Aims 1 and 2 comprise a sequential explanatory mixed methods study to evaluate barriers to
CR enrollment among Veterans. The purpose of Aim 1 is to quantify barriers to CR in 100 Veterans
hospitalized with ischemic heart disease using the previously validated Beliefs About Cardiac Rehabilitation
Scale (BACRS). The purpose of Aim 2 is to reveal additional barriers to outpatient CR enrollment through
qualitative interviews in 30 Veterans from Aim 1 who did not enroll in CR. Aim 3 focuses on the iterative
development of a tailored intervention to increase outpatient CR enrollment in 3 groups of 5 hospitalized
Veterans, characterizing the intervention’s feasibility and acceptability. In Aim 4, the tailored intervention will
undergo proof-of-concept testing in a non-randomized group of 25 Veterans hospitalized with ischemic heart
disease. The applicant hypothesizes that these Veterans will have a clinically significant improvement in
BACRS summary scores after the intervention, representing a decrease in perceived barriers to CR.
Methodology: Aim 1 will quantitate the burden of CR barriers among Veterans by evaluating distributions of
BACRS summary scores and subscales. In Aim 2, the applicant will use intensity sampling to purposefully
select Veterans with the lowest individual BACRS subscale scores (and highest perceived barriers to CR) from
the Aim 1 cohort for semi-structured qualitative interviews. Aim 3 will use mixed data from Aims 1 and 2 and
serial formative evaluations to inform the iterative development of a tailored intervention. In Aim 4, the BACRS
will be administered before and after the intervention, characterizing the intervention’s effect on perceived
barriers to CR enrollment as measured by the BACRS summary score.
Implementation/Next Steps: The applicant will align the study activities with the QUERI Implementation
Roadmap and convene a Stakeholder Engagement Panel to ensure that the tailored intervention is developed
with maximum generalizability to other VA facilities. Findings from the proposed study will inform a wide range
of initiatives related to CR enrollment among Veterans and will be used to conduct a randomized clinical trial of
the tailored intervention within the context of an Investigator Initiated Research application.

Public health relevance
Cardiac rehabilitation, an outpatient program that includes supervised exercise and cardiovascular risk factor education, is one of the most important therapies for patients with cardiovascular disease. Unfortunately, very few Veterans with cardiovascular disease enroll in cardiac rehabilitation programs. This proposal will evaluate Veterans’ individual barriers to attending cardiac rehabilitation with both surveys and interviews. Using this information, we will develop a behavioral intervention to encourage Veterans to enroll in outpatient cardiac rehabilitation programs. This intervention will be individually tailored to Veterans with the information- motivation-behavioral skills model, a theory of behavior change. We will test the tailored intervention with a proof-of-concept study in Veterans hospitalized with cardiovascular disease at the Veterans Affairs Tennessee Valley Healthcare System. This project is relevant to Veterans’ health because increasing enrollment in cardiac rehabilitation will decrease mortality and increase quality of life in Veterans with cardiovascular disease.